Mechanisms by which human milk-derived oligosaccharides protect intestinal barrier and attenuate inflammation

Summary
Dysfunction of the intestinal barrier established by tight junctions between intestinal epithelial cells (IECs)
is a critical issue for many diseases, including inflammatory bowel diseases and mucositis as a severe
complication of chemotherapy. There is an unmet need in efficiently preventing dysfunction of the intestinal
barrier. Observational evidence suggests that oligosaccharides in human milk are associated with beneficial
effects in infancy and in adulthood. However, neither basic research nor clinical studies have revealed the exact
biological functions or mechanisms of action of individual oligosaccharides during development or in adulthood.
Thus, it remains largely unknown whether these oligosaccharides could become effective therapeutics. 2’-
fucosyllactose (2’-FL) is the most abundant oligosaccharide in human milk but are not present in dairy milk. We
have found a previously unrecognized role of 2’-FL in protecting intestinal barrier and ameliorating intestinal
injury during colitis and mucositis in adult mice. Our preliminary studies have demonstrated that dysregulated
microbial metabolic pathways in ulcerative colitis patients are regulated by 2-FL in adult mice. We have further
found that 2’-FL promotes Bifidobacterium infantis to produce metabolites, such as pantothenate that protects
the intestinal barrier against oxidative stress. Another important finding is that 2’-FL directly stimulates
transactivation of a cell protective signaling, epidermal growth factor receptor (EGFR) in IECs.
We will test the hypothesis that 2’-FL protects the intestinal barrier against injury during intestinal
inflammation in adulthood through two mechanisms: by promoting the growth of beneficial bacteria capable of
metabolizing 2’-FL, and by stimulating transactivation of EGFR in IECs in a microbially-independent manner.
The mechanisms underlying protecting the mucosal barrier in intestinal inflammation by human gut microbiota
consuming 2’-FL will be defined in Aim 1. We will define the impact of 2’-FL on the adult human gut microbial
compositional balance, particularly growth of 2’-FL consuming bacteria, and metabolite production and determine
the exact roles of 2’-FL-regulated microbial profile and metabolites, such as pantothenate, in protecting the
intestinal barrier against injury in colitis and mucositis in adult mice. We will further identify 2’-FL-directed
pathways that mediate growth and metabolism in B. infantis and B. breve. In Aim 2, we will determine the
mechanisms by which 2’-FL directly stimulates cellular responses in IECs that ameliorate inflammation-induced
disruption of the intestinal barrier through identifying novel targets of 2’-FL in IECs, including targets for EGFR
activation, revealing protective cellular response through 2’-FL-stimulated EGFR signaling in IECs and further
define these cellular programs at single cell resolution in the human intestinal epithelium, and defining the
contribution of 2’-FL-stimulated EGFR signaling in IECs to preservation of the epithelial barrier and enhancement
of epithelial regeneration in colitis and mucositis in adult mice. Results from this proposal will support 2’-FL as
novel therapeutic strategies for diseases associated with impaired intestinal homeostasis.

Public health relevance
Project Narrative This proposal will elucidate novel mechanisms through which 2'-fucosyllactose, the most abundant oligosaccharide in human milk, preserves intestinal barrier function against injury under inflammatory condition in adulthood, thus these studies have significant relevance to human health by laying a foundation for developing human milk-derive oligosaccharides for adults as a therapy for diseases associated with deteriorating intestinal homeostasis.